CollaLink: Guided-regenerative Scaffold for Augmentation of Anterior Cruciate Ligament Repair

Summary
Tears of the anterior cruciate ligament (ACL) lead to instability of the knee and reduce mobility. An estimated
225,000 ACL tears are reported annually in the US, equating to ~$7B in medical costs. The preferred treatment
is reconstruction of the patient’s ACL with an autograft or allograft, which can cause donor site morbidity or
immunological response, and have an increased risk of chronic knee conditions, like osteoarthritis. With new
advances in surgical techniques and biological augmentations, ACL primary repair methods have gained
renewed interest to save a patient’s native tissue, helping prevent long-term knee problems. Lately, primary
repair of the ACL is designated for proximal ACL tears only whereas mid-substance tears are not repaired
primarily due to high rate of failure. To the best of our knowledge, there is no other biologic augmentation on the
market for primary repair of mid-substance tears. Therefore, there is a clinical need for technologies that will
enable primary repair of mid-substance tears. CollaMedix Inc. develops biotextile medical implants using high-
strength pure-collagen threads produced by its patented high-throughput electrochemical compaction process.
Spooled threads manufactured at CollaMedix are braided by industrial braiding machines to obtain CollaLink, a
tubular braid that is deployed simply by sliding over the ACL tear and sutured into place to span the mid-
substance tear during the repair process. Besides surgical applicability, CollaLink has regenerative effects.
Collagen molecules are unidirectionally aligned within threads, mimicking the native topography of ligaments
and tendons. Host collagen is templated parallel to these threads, resulting in an ordered tissue deposition.
Extensive research has shown collagen threads impart a tenoinductive effect on stem cells topographically. The
crosslinking agent genipin, which is used to stabilize threads, polarizes macrophages to the pro-regenerative
phenotype. Through this Phase I project, CollaMedix aims to establish the feasibility of the CollaLink as
an ACL repair augmentation that will enable primary repair of ACL mid-substance tears in a porcine
model. We hypothesize that CollaLink placed around a mid-substance ACL tear will provide a macroporous
scaffolding for fibroblast infiltration and de novo collagen deposition throughout the continuum of the scaffold
and promote a pro-regenerative environment for improved ligament healing and mechanical load strength. In a
paired design, pigs’ ACLs will be transected at the mid-substance, and each leg will be repaired with sutures
either with or without a CollaLink. At 12 weeks post-implantation, the ligaments will be mechanically tested for
laxity and strength, and processed for immuno/histology for biocompatibility, tissue integration, and matrix type.
Successful attainment of Phase I would justify future Phase II work to test CollaLink against reconstruction and
other predicates and develop an arthroscopic delivery tool and protocol. Commercialization of CollaLink offers
impactful benefits such as preservation of the patient’s own ligament, elimination of donor site morbidity in
autografting, and reducing the occurrence of long-term osteoarthritis of the knee.

Public health relevance
Narrative The anterior cruciate ligament is a commonly torn ligament in knee injuries that require corrective surgery but the current gold standard surgical procedure, a reconstruction, can lead to long-term knee problems, such as osteoarthritis, due to the removal of the patient’s ACL. This project will determine the feasibility of a novel regenerative ACL augmentation to repair the patient’s native ACL through regeneration of ligament-like tissue deposition at the repair site, resulting in reduced chronic knee problems. The new product will be tested in a clinically relevant large animal model.